Phenotype core - The NINDS International Stroke Genetics Consortium Study

The Consortium Phenotype Core will be created out of the currently active SWISS Phenotype Committee. The Phenotype Core will serve mainly a quality control function in this application, but will have the ability to respond to broader goals and objectives like imaging and outcome phenotypes should additional resources permit.